Monitoring acute and longer-term effects of cannabis on psychomotor performance in daily life in medical cannabis patients

ABSTRACT
Although therapeutic use of cannabis is increasing, findings are mixed regarding therapeutic effects of
cannabis for certain conditions, such as anxiety. Further, acute cannabis effects could adversely impact
psychomotor performance (e.g., slowed reaction time), with subsequent negative effects on daily activities
(e.g., work performance, driving skills). Low burden methods to monitor acute cannabis effects through
sensors in personal smartphones could ultimately help reduce cannabis's acute negative effects on
psychomotor performance by helping to raise a person's awareness of cannabis-related impairment. Toward
this goal, this R01 will collaborate with individuals who use medical cannabis (MC) in monitoring, with their
smartphone, acute therapeutic and adverse effects of cannabis use. Individuals who use MC commonly report
cannabis use to relieve chronic pain and/or anxiety, the two conditions of interest for this R01. Smartphone will
be used to conduct symptom monitoring of acute cannabis effects on chronic pain and anxiety using Ecological
Momentary Assessment (EMA). Phone sensor data will be used to examine acute cannabis effects on
psychomotor performance. These fine-grained smartphone "micro" data (e.g., momentary-level) will be
combined with longer-term follow-up over 1-year, to examine the impact of cannabis use at a more "macro"
level (e.g., over months), because cannabis effects (e.g., on anxiety) at "micro" and "macro" time scales may
differ. This R01 will recruit individuals who report therapeutic use of cannabis, with chronic pain and/or anxiety
as the primary reasons for MC use (N=400, age >18; 50% female). Participants complete lab assessments at
baseline, 3-, 6-, and 12-months in a repeated measures design. Saliva sample for THC and CBD level will be
done at baseline, 3-, 6-, and 12-months. Each assessment (baseline, 3-, 6-, 12-months) is followed by 14-day
daily EMA and phone sensor data collection. Daily EMA (3x/day) and self-initiated EMA of cannabis use
(medical, non-medical) will be used. Phone sensor data include, for example, keyboard use (not message
content), and accelerometer (e.g., to detect activity level). Study aim 1 will examine links between acute
cannabis use and effects (EMA report), psychomotor performance (phone sensor data), and self-reported daily
cognitive functioning (e.g., react slowly to things). Study aim 2 will test links, over 1-year, of longer-term effects
of cannabis use, computerized measures of psychomotor performance, and self-report of cannabis-related
consequences. For each aim, gender differences in cannabis's short and longer term effects will be explored.
The combination of fine-grained subjective (EMA) and objective (phone sensor) data, collected at micro (EMA)
and macro time scales over 1-year, will help resolve mixed findings on possible cannabis-related therapeutic
benefit, acute risks, and longer-term outcomes (e.g., on psychomotor performance). In line with NIDA priorities,
this R01's novel combination of symptom monitoring methods (EMA, phone sensor data), and "micro" and
"macro" data, will guide development of mHealth interventions that reduce risk for cannabis-related harm.

Public health relevance
Project Narrative Methods to monitor acute cannabis effects in real-time could reduce potential cannabis-related harm by raising a person's awareness of possible cannabis-related impairment, for example, on psychomotor performance (e.g., slowed response). Toward this goal, this project will collaborate with individuals who use cannabis for therapeutic purposes in monitoring, using their smartphone, the acute therapeutic and adverse effects of cannabis use, and will combine this fine-grained data with follow-up over 1-year because cannabis effects may differ at shorter (daily) and longer time scales (over months). In line with NIDA priorities, this project's novel combination of smartphone symptom monitoring and longer-term follow-up will guide the creation of real-time interventions to reduce cannabis-related impairment and harm.